Interplay between PDGFRA, oxygen-regulated translation and KSHV in Kaposi's sarcomagenesis

In spite of our understanding of KSHV pathogenesis and the implementation of rationally designed therapies
based on these advances, advanced KS is mostly an incurable disease and many of the most promising new
therapies continue to have major roadblocks and implementation problems in the setting of ART. We have shown
that 1) KSHV lytic genes; and particularly the vGPCR oncogene can induce- PDGF mediated activation of
PDGFRA and that this is the most prominently activated RTK in AIDS-KS and it is an oncogenic driver and a
therapeutic target in KS. 2) We identified PDGFRA (+) mesenchymal stem cells as KS progenitors; and
PDGFRA, as an enabler of KSHV oncogenesis in an angiogenic KS like environment and we developed of a
new KSHV infection-to-tumorigenesis system that allows to dissect the effect of the angiogenic
microenvironment and the contribution of viral and host mechanisms to oncogenesis 3) We found that the ability
of the virus to regulate the oxygen sensing machinery allowed the virus to coopt the hypoxia-regulated alternative
translation initiation machinery eIF4EH activated by HIF2a and mediated by eIF4E2 alternative cap-binding. This
was essential for KSHV replication, for escaping the viral shut-off and for PDGFRA driven pathogenesis in MSCs.
The importance of this discovery is that through its regulation of the oxygen sensing machinery the
virus access to translation initiation plasticity, defined as the ability for KSHV to alternatively initiate
protein synthesis using both the initiation complex eIF4E bearing a cap-binding regulated by the PI3K-
AKT-mTOR -HIF1a (eIF4E1 cap-binding) axis or the eIF4EH (eIF4E2 cap-binding) regulated by the HIF2a.
We hypothesize that this provides the virus with several adaptive advantages that we will study: 1) Allows the
virus to maximize replication in different oxygen levels corresponding to variety of tissues and pathophysiological
conditions and it may allow the virus to bypass the stress and innate immunity-related kinases targeting eIF2a
inhibition 2) It may be employed by viral oncogenes such as vGPCR and/or by its host-cell signaling mediators
such as PDGFRA for proliferation and the induction of direct and paracrine oncogenesis 3) Could allow the
transformed host cell to be plastic and adaptive in the context of AIDS-KS therapies targeting PDGFRA such as
Imatinib, which are known to target the PDGFRA-AKT-mTOR-E1-HIF1a pathway. We will employ the MSC
based de novo oncogenesis to tumorigenesis models, an induction reactivation model and two natural infections
systems and AIDS-KS samples from different repositories to test these hypotheses. Aim 1: Study how KSHV
regulation of the oxygen sensing machinery (O2SM) leading to HIF2a activation of translational initiation by
eIF4EH contributes to KSHV replication and innate immunity evasion. Aim 2: Study mechanisms whereby KSHV
regulation of the oxygen sensing machinery leading to HIF2a activation of translational initiation by eIF4EH
contributes to KSHV oncogenesis in mouse MSC and human MSCs. Aim 3: Role of translation initiation plasticity
in mediating resistance to PDGFRA targeted therapies.

Public health relevance
In spite of advances due to anti-retroviral therapy and rationally designed therapies AIDS-associated Kaposi’ sarcoma continues to be a global health problem affecting many HIV at-risk populations. It is caused by human cancer causing-virus the Kaposi’s sarcoma herpesvirus that can infect and transform human. Research on the molecular and cellular mechanisms whereby the KSHV virus causes KS, will aid our understanding of this viral disease and help design and test therapies.